Great Plains Rare Disease Summit

PROJECT SUMMARY
Rare diseases are defined as those diseases affecting less than 1 in 5000 patients in the US. Although singularly
rare, combined there are over 7000 rare disease that affect approximately 1 in every 10 Americans. For these
patients, it is often difficult to find or build patient support networks or gain access to the latest research on their
particular rare disease. The team in the Sanford Research's Coordination of Rare Diseases at Sanford (CoRDS)
registry program has a nine-year history of hosting an annual rare disease symposium for medical professions,
scientists, rare disease patients, and patient advocates. This event, which started as a grassroots effort, serves
as a collaborative research summit drawing attendees from across the Great Plain states. With this proposal,
our goal is to grow this once one-day event into a multi-day Great Plains Rare Disease Summit that will provide
access to the highest standard of scientific and clinical research in a format that is accessible to patients,
advocates and community members. Incorporating this mix of attendees encourages communication between
the research and patient communities. Investigators will come away from the meeting having heard the patient's
story and have a better understanding of how the disease impacts the person. Likewise, patients and advocates
will come away with a better scientific understanding of their condition and can go back to their communities as
more effective and energized advocates for rare disease research and awareness. Although rare disease events
are held across the US, none are held consistently in the Great Plains region. For families and patient advocacy
groups with high medical costs and health barriers, attending these events can be cost prohibitive or logistically
challenging. By bringing the conference to the region in which they live, we are providing a much needed,
mutually beneficial connection to the research world.
Our objective is to establish the Great Plains Rare Disease Summit as a destination conference for scientists,
medical professionals, patients, advocates, and industry throughout the US. Each year, the conference will
promote groundbreaking research in rare diseases and provide an important avenue for conversation between
scientists, clinicians, and those affected by the diseases they study and treat. We will achieve these objectives
by 1) providing rural rare disease patients, caregivers and advocates access to a high quality rare disease
education and support; 2) providing a forum for experts to present cutting edge research; 3) building up the rare
disease community in the region for patients, caregivers, and advocates; and 4) developing an innovative new
program that promotes rare disease education and research in the Great Plains.

Public health relevance
PROJECT NARRATIVE The Great Plains Rare Disease Summit held at Sanford Research in Sioux Falls, SD will be a dual scientific and community conference. The first day of the summit is devoted to current updates from clinicians and rare disease researchers. The second day of the summit is tailored to patient advocacy groups, patients, and caregivers. The goal of the summit is to foster new relationships between research and advocacy, while building a robust community of rare disease advocates across both spectrums.